Structural and Functional Roles of Membrane Lipids in the pH gating of Connexin-46/50 Channels.

Project Summary
Connexin 46 and 50 (Cx46/50) gap junctions are critical for maintaining lens transparency, and disruption of
proper gap junction function results in the world’s leading cause of blindness: cataract. Cx46/50 gap junctions
couple adjacent lens fiber cells together and regulate the lens microcirculatory system, which is responsible for
circulating ions, nutrients, and waste products from the oldest to the newest cells. Lens fiber cells rely on
anaerobic mechanisms to generate ATP; thus, over time the intracellular pH drops below physiologically neutral
conditions. In vitro experiments have shown that Cx46/50 gap junctions are gated under low pH conditions –
providing a plausible mechanism contributing to age-related cataract. Preliminary structural data demonstrates
that annular membrane lipids can intercalate the inner pore of Cx46/50 under conditions at pH 5.8, and that this
pore lipid gating phenomenon is reversible when proteins are returned to pH 7.4. However, it is completely
unknown how lipids enter and exit the pore and even if lipids functionally gate Cx46/50 gap junctions in a cellular
context. Therefore, the primary goals of this project are to 1) determine the functional role of lipids on Cx46/50
pH gating in a cellular environment and 2) determine the mechanistic pathway of lipid entry into the pore of
Cx46/50 gap junctions. For Aim 1, my approach will employ a combination of a chemical biology toolkit together
with cellular functional assays to determine the role of lipids in the pH gating of Cx46/50 in a cellular environment.
Additionally, suspected pH-sensing amino acid residues will be systematically mutated to determine their role in
pH-induced channel closure. For Aim 2, my approach will use a combination of structural biology methods
utilizing cryo-electron microscopy together with proteomic approaches to detail the protein-lipid interactions that
define the pH-dependent translocation pathway of lipids into the Cx46/50 pore. Success in these studies will
clarify critical mechanistic details of how Cx46/50 functionally interact with lipid membranes to respond to
intracellular changes in pH. These insights are expected to provide molecular level insights into age-related
cataract, with potential broad relevance to understanding how other connexins respond to pH-induced stress
conditions.

Public health relevance
Project Narrative Gap junctions facilitate the flow of electrolytes, nutrients, and waste in the human lens, and the age-related loss of this function is a major contributor to cataract disease. While the regulation of gap junction channels by acidification (i.e., pH) has been extensively studied and linked to diseases such as stroke, heart attack, and cataract, the precise mechanism of pH-induced gap junction closure remains unknown. This study aims to elucidate the molecular details, including the putative role of lipids, describing the response of lens gap junctions to pH changes associated with aging.